Biomedical Engineering Social Networks

PROJECT ABSTRACT
Thousands of students yearly are drawn to biomedical engineering (BME) by the prospect of a career linking
medicine and engineering. Unfortunately, students from historically underrepresented racial/ethnic minority
(HU; e.g., Hispanic\Latinx) groups do not advance or integrate into the BME professional community at rates
comparable to their majority peers. National statistics indicate that Hispanic, Black, and non-Hispanic
racial/ethnic minority groups accounted for only 12% of bioengineering and BME graduates in 2021. Data
collected at Texas A&M University, a Hispanic Serving Institution and ranked 5th nationally in bachelor’s
degrees awarded in BME in 2022, show that students from HU groups (on average ~25% of BME majors, up
to 33% in recent years) lag behind their peers from historically overrepresented (HO) groups on measures of
academic success (e.g., time to graduation). Social Network and Mentoring Co-Regulation theories, and
preliminary data suggest these disparities may be due to HU students holding less privileged positions within
their peer network, having less access to mentors, and therefore having less access to social capital (i.e.,
information, support, and resources) and support for self-regulated learning (SRL; e.g., help-seeking). The
long-term overall objectives of this work are to develop a generalizable model of how social networks facilitate
students’ biomedical research career success and to diversify the BME research workforce. This study will (1)
examine the impact of generalizable “Creating Birds of a Feather” (CBoaF) peer and mentor network
interventions designed to promote diverse students’ “Hallmarks of Success” outcomes (e.g., well-being, GPA,
degree conferral), and (2) assess the contributions of students’ SRL and social capital. The central hypothesis
is that being well-connected within peer and mentor networks will promote access to social capital and support
for effective SRL, which will promote success in BME. The project will implement a longitudinal, randomized
experiment via a professional development workshop across three cohorts (2024-2026) of first-year BME
majors to ensure a large and diverse sample of emerging biomedical engineers (N=360) from HU (n=108) and
HO (n=252) groups. Aim 1 will test a peer network intervention by randomly assigning students to one of three
workshop groups: (1A) CBoaF enhanced inclusive activity workshop at a Mixed Low/High table (containing
students with low and high connections with peers), (1B) CBoaF enhanced inclusive activity workshop at a
Same-level table (i.e., low-only, high-only), or (1C) Alternative workshop control group without CBoaF
activities. Aim 2 will test a mentor network intervention by randomly assigning students to one of two mentor
introduction groups: (2A) Introduction + CBoaF similarities highlighted or (2B) Introduction only. Exploratory
Aim 3 will assess the degree to which intervention effects are stronger for students from HU groups compared
to their HO group peers. This study will show how and why helping diverse BME students form stronger social
networks can promote their well-being and BME career success.

Public health relevance
NARRATIVE Building on social network and mentoring co-regulation theories, we propose to develop a generalizable model of how peer and mentor social networks can be leveraged to promote diverse students’ access to social capital and support for self-regulated learning skills, which in turn facilitate biomedical research career success. We propose to use a longitudinal experimental design to compare short-, medium-, and long-term “Hallmarks of Success” (e.g., well-being, degree conferral) of diverse first-year biomedical engineering students. Participating students will be assigned to one-of-three peer-network intervention groups and one-of-two mentor-network intervention groups, and the differential intervention effects for students from historically over- and under- represented racial/ethnic groups will be assessed.